STRUCTURE & CONFORMATIONAL DIVERSITY OF AMYLOID AGGREGATES BY FCS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Study the different conformations of amyloid aggregates and their recognition by conformation-specific antibodies both in vitro and in vivo, using the FCS approach.